Retina-derived extracellular vesicles in diabetic retinopathy: their potential role in pathogenesis and therapy

Project summary.
Extracellular vesicles are cell-derived membranous structures harboring a variety of biomolecules. Their
secretion and cargo are determined in part by the physiological or pathological conditions that the parent cell is
exposed to. Recently, increased levels of extracellular vesicles in plasma have been associated with the
pathogenesis of diabetic retinopathy, but from where those plasma extracellular vesicles originated from, and
whether they affect the development of the disease is still under investigation.
Early in my postdoctoral training, I established a modified protocol to isolate extracellular vesicles from small
tissues, including retina. Using this protocol, I isolated extracellular vesicles of retina explants from nondiabetic
and diabetic mice and found that diabetic retina-derived extracellular vesicles induce ICAM-1, an important
adhesion molecule, in retinal endothelial cells in vitro. This induction is inhibited by pharmacological blockage of
TLR4, a transmembrane protein that has been proposed as an extracellular vesicles cell receptor. I also found
that diabetic retina-derived extracellular vesicles activate circulating leukocytes isolated from nondiabetic
animals. This work laid the foundation of my ongoing research. I want to determine the mechanism(s) of how
retina-derived extracellular vesicles induce ICAM-1 in retinal endothelial cells and activate circulating leukocytes
using a mouse model of diabetes.
I propose 3 specific aims:
Aim 1, To determine if a diabetes-modified visual cycle activity in photoreceptor cells modulates the retina-
derived extracellular vesicles phenotype, which lead to the induction of ICAM-1 in retinal endothelial cells and
activation of circulating leukocytes.
Aim 2, To determine if TLR4 is the common receptor present in retinal endothelial cells and leukocytes and is
triggered upon binding of retina-derived extracellular vesicles, leading to the induction of ICAM-1 in retinal
endothelial cells and activation of circulating leukocytes in diabetes.
Aim 3, To determine if rod-derived extracellular vesicles are key contributors to the retinal vascular pathology
characteristic of diabetic retinopathy.
These studies will be conducted in vivo using mice genetically deficient in key proteins of the visual cycle and
pharmacological means to inhibit extracellular vesicles secretion and TLR4 receptor in diabetes. This proposal
is novel because it focuses on (i) the role of retina (and rod)-derived extracellular vesicles in the pathogenesis
of the retinopathy, (ii) the role of the visual cycle in the cargo sorting of retina (and rod)-derived extracellular
vesicles, and (iii) the role of TLR4 as a receptor of retina (and rod)-derived extracellular vesicles. The insights
learned from these studies can lead to the development of novel and effective targeted therapies to inhibit the
etiopathogenesis of diabetic retinopathy.

Public health relevance
Project narrative. Diabetic retinopathy is a vascular complication of long-term diabetes, and the vascular complications of diabetes are associated with increased levels of extracellular vesicles in plasma, but from where those extracellular vesicles originated from has not been defined. Evidence that neural retina contributes to the etiopathogenesis of diabetic retinopathy is accumulating, and the research proposed in this application will unravel the role of retina- derived extracellular vesicles in the disease. I propose a multipronged approach to understand the influence of retina-derived extracellular vesicles in the development of diabetic retinopathy, the role of the visual cycle in their cargo sorting, and potential therapies to inhibit the interaction of retina-derived extracellular vesicles and the recipient cells, including retinal endothelial cells and leukocytes.